NYU-CUNY Prevention Research Center - Revision - 5- 24-003

Project Summary/Abstract
The New York City (NYC) Cancer Prevention and Control Research Network Collaborating Center (CPCRN)
builds on the multi-disciplinary expertise and community partner networks of the NYU-CUNY Prevention
Research Center (PRC), including the City University of New York (CUNY) School of Public Health, the NYU
Langone Health’s Department of Population Health, and NYU Langone Perlmutter Cancer Center, an NCI-
designated Comprehensive Cancer Center. The goals of the NYC CPCRN are to employ social determinants of
health (SDoH) strategies to reduce preventable cancers, increase early cancer screening and detection, and
improve cancer equity among low-income, minoritized populations in urban areas. The technical assistance,
training, and dissemination activities we offer are centered on participatory approaches, disaggregated data
collection, cultural adaptation, and implementation of evidence-based cancer prevention and control strategies
relevant to diverse, urban communities in place-based and clinical settings. For the five year period, we propose
conducting two studies that will each leverage an established network of NYC community and clinical partners
serving the Asian American, Black, Latine, and other understudied immigrant communities in order to reduce
cancer disparities and improve cancer control. The first study is implementation evaluation to assess the factors
that impact the reach, effectiveness, and adoption of clinical decision support and culturally and linguistically
adapted materials to improve lung cancer screening rates among low-income, multi-ethnic communities in NYC.
Using a participatory approach to engaging multiple stakeholders and diverse communities, we will apply RE-
AIM and the Consolidated Framework for Implementation Research to evaluate, refine and optimize clinical-
community strategies focused on improving lung cancer screening among Asian American, Black, Latine, and
other understudied immigrant communities. We also propose a second formative research study, to inform a
multi-level, healthcare provider intervention to improve human papilloma virus (HPV) vaccine rates among high-
risk and understudied communities in NYC, specifically Arab- and Mexican American. The proposed NYC
CPCRN application is aligned with Healthy People 2030 cancer-related objectives to increase the proportion of
adults who receive screening for lung cancer and to improve HPV vaccination rates. Research will focus on
strengthening community-clinical linkage models, employing CHW strategies for cancer patient navigation, and
tackling SDoH to reduce cancer disparities and advance equity. The NYC CPCRN will also continue to actively
engage and collaborate with partners across the network in joint work and interest group activities.

Public health relevance
Project Narrative The New York City (NYC) Cancer Prevention and Control Research Network Collaborating Center (CPCRN) of the NYU-CUNY Prevention Research Center (PRC) aims to continue its collaborative work across the CPCRN network and employ social determinants of health (SDoH) strategies to reduce preventable cancers, increase early cancer screening and detection, and improve cancer equity among low-income, minoritized populations in urban areas. We propose conducting two core projects that will each leverage an established network of NYC community and clinical partners serving Asian American, Black, Latine, and other understudied immigrant communities in order to reduce cancer disparities and improve cancer control. The first is an implementation research evaluation to assess the impact of evidence-based strategies to improve uptake and adoption of lung cancer screening among high-risk, low-income racial and ethnic minoritized communities in NYC, and the second will conduct a formative research assessment to inform a multi-level, healthcare provider intervention to improve human papilloma virus (HPV) vaccine rates among high-risk and understudied communities in NYC.